Advanced development of human KDM5 inhibitors (Chemical Biology Consortium/NCI Experimental Therapeutics Collaboration)

During this period, the NCATS group, as part of the KDM5 collaborative team, has worked to develop a large panel of HTS-amenable assays in a number of orthogonal formats, perform primary screening against a number of small molecule libraries, and pursue medicinal chemistry to further refine compound potencies. As a center, the NCGC has fostered and maintained over 130 active collaborations with both NIH and extramural investigators, facilitating drug discovery efforts across the entire spectrum of human disease. These efforts have led to dozens of high-throughput screens and a number of medicinal chemistry campaigns to further improve on screening hits, providing our collaborators and the general research community with publications and a variety of promising small molecule probes and leads. In addition, the NCGC has worked to advance a number of informatic initiatives to make better use of existing drug and disease target information and provide the general public with easily accessible resources, further catalyzing the development of new therapies for human disease.